Optimizing a Sensor-Enabled mHealth Intervention for Adolescents with Suboptimal Asthma Control

PROJECT SUMMARY
Asthma affects 9% of adolescents in the United States and is a leading cause of youth morbidity. National
asthma guidelines emphasize the importance of asthma self-management behaviors to control asthma and
promote quality of life. Adolescents have suboptimal adherence to asthma self-management behaviors driven
by an underdeveloped and highly variable capacity to self-regulate cognitions, emotions, and behaviors; and a
normative decrease in parental support while multiple demands are increasing. Each adolescent experiences
different threats to their ability to self-regulate at different moments in time, necessitating personalized and
adaptive self-regulatory support to increase daily self-management behaviors and achieve sustained asthma
control. Smartphones are an optimal mechanism for improving adolescent adherence, however, existing
asthma self-management apps do not combine what is known about evidence-based behavior change
strategies and adaptive intervention technologies that tailor the experience based on user data. Our team
recently developed Responsive Asthma Care for Teens (ReACT; R56 HL141394), a technological ecosystem
including a smartphone app, mobile sensors to assess medication dosing, a Smarthub to achieve real-time
data listening, and cloud-based intervention delivery algorithms. ReACT provides personalized and adaptive
self-regulatory support to improve asthma self-management via goal-setting, feedback, and barrier
identification with problem-solving skills. Results of our pilot work demonstrated that ReACT was acceptable
and produced post-intervention changes in our hypothesized mechanisms of self-regulation and problem-
solving skills. The proposed study will optimize ReACT based on lessons learned from our pilot work and
updated national asthma guidelines. We will conduct an unbalanced (2:1) randomized pilot trial to examine
feasibility of our multisite trial protocol, determine if ReACT produces a clinically significant effect on proximal
mechanisms hypothesized to drive asthma control, and explore the impact of ReACT on asthma control and
asthma-related quality of life. Adolescents ages 13-17 with suboptimal asthma control (n=120) will be
randomized to ReACT or a mHealth control condition stratified by regimen for 6-months. Adolescents in the
control condition will receive an app that includes static asthma education information and a form for recording
symptoms and adherence. The control condition is designed to mirror standard of care, optimize recruitment,
and sustain interest while concurrently having a minimal impact on asthma management. Assessments will
occur at baseline, 3-month, and post-intervention (6-month) time points. Mechanisms of intervention effect will
be collected via both self-report (e.g., self-regulation) and objective (e.g., medication adherence) assessments.
We will assess planned future clinical trial outcomes (e.g., asthma control and asthma-related quality of life) to
provide effect size estimates for future work. We will have the necessary and sufficient information about the
feasibility of our multisite clinical trial protocol and planned analyses at the end of this project.

Public health relevance
PROJECT NARRATIVE Adolescents diagnosed with asthma have difficulties consistently completing disease self-management behaviors (e.g., taking medications as prescribed, monitoring symptoms), placing them at elevated risk for suboptimal asthma control and impaired quality of life. The proposed project will evaluate a mobile health intervention that provides personalized and adaptive support to improve asthma self-management in adolescents with suboptimal control. If successful, our smartphone-based intervention has potential to improve health outcomes for many adolescents diagnosed with asthma.